Measuring Language Comprehension Development in the Primary Grades

PROJECT SUMMARY
Developmental language disorder (DLD) is a highly prevalent neurodevelopmental disorder with significant
impacts on many aspects of life functioning including literacy, educational attainment, and employment
opportunities. Unfortunately, most children with DLD are not identified and do not receive services to improve
their outcomes. The long-term goal of this project is to improve the identification of DLD and to contribute to
improved systems of support for language and literacy development for all children. We will characterize the
developmental trajectory of language comprehension in the primary grades using novel, group-administered
measures focusing on skills which (a) undergo significant development in the primary grades, (b) appear
frequently in academic settings, (c) are important for reading comprehension, and (d) are appropriate for use
with students from diverse cultural and linguistic backgrounds. The use of group-administered measures
promotes feasibility and allows for practical implementation in real-world classrooms. Items measuring syntax,
vocabulary, and derivation of novel word meanings will be developed and calibrated to create an across-grade
vertical scale of measurement for language performance. Developmental change in language comprehension
will be evaluated with three administrations of language comprehension measures per year in grades K and 1
(e.g., Fall, Winter, Spring) and one administration in grade 2. We will evaluate the clinical and educational
validity of the novel language comprehension measures by conducting an accelerated cohort design study
spanning grades K through 3 and relating them to standardized measures of language and reading abilities
that will be administered once in each grade. Clinical utility will be examined using (a) traditional binary
classification analyses of sensitivity, specificity, and likelihood ratios, and (b) with cutting-edge continuous
measurement models. The latter models will estimate individual change along a continuum, allowing us to
evaluate student trends over time rather than simplistic pass-fail criteria, which may be arbitrary and
inconsistent. This information will help clinicians identify when children may appear to be achieving adequately
but at risk of approaching a clinical threshold, as well as when children receiving language supports are rising
back up toward a level of performance more typical of their peers or level of instruction.

Public health relevance
PROJECT NARRATIVE This longitudinal project will chart the trajectory of language comprehension in the primary grades and develop and validate measures of language comprehension which are important for literacy and academic progress. This project is relevant to the NIDCD’s mission to improve the lives of individuals with communication disorders because results will yield improved identification of children with developmental language disorder (DLD) as well as other children with language difficulties that may impact reading comprehension and other academic skills, allowing for earlier treatment to promote positive outcomes. This project is also relevant to the broader field of public health because of the importance of language and reading skills to overall quality of life.